Glomerular Disease Mechanisms mediated by Podocyte TRPC6

DESCRIPTION (provided by applicant): This project aims to delineate disease causing mechanisms of dysfunctional ion channel TRPC6 in podocytes. TRPC6 is part of the slit diaphragm relating Ca2+ signals into podocyte foot processes and mutated TRPC6 or induced expression of wild type TRPC6 protein can cause hereditary and acquired proteinuric diseases, respectively. Thus, (dys-) regulation of TRPC6 likely affects millions of patients with glomerular disease. We have generated novel preliminary data demonstrating a unique functional interaction between TRPC6 and synaptopodin producing a regulatory loop, that coordinates physiological podocyte function but triggers podocyte injury in the case of dysregulated TRPC6 mediated Ca2+ signals. We propose to test our central hypothesis that TRPC6 and synaptopodin cooperate in the regulation of the dynamic podocyte actin cytoskeleton. While synaptopodin binds to TRPC6 and regulates its membrane expression, TRPC6 mediated Ca2+ influx determines the stability of synaptopodin through Ca2+ sensitive enzymes calcineurin and protein kinase A (PKA). According to our novel data, increased TRPC6 channel activity disrupts normal podocyte actin cytoskeletal dynamics via the activation of calcineurin that in turn leads to the degradation of synaptopodin thereby causing proteinuric kidney disease. In addition, diminished TRPC6 mediated Ca2+ influx into podocytes leads to reduced activity of PKA and thus reduced protective synaptopodin phosphorylation with its subsequent degradation. Normal Ca2+ transport of TRPC6 maintains physiological synaptopodin levels that allow a dynamic regulation of the podocyte foot process system and kidney barrier. Specific Aim 1 will address how TRPC6 regulates synaptopodin-mediated actin cytoskeletal dynamics. Specific Aim 2 seeks to define how synaptopodin affects TRPC6 channel activity and localization. In Specific Aim 3, we will study the consequences of TRPC6 deficiency and TRPC6 hyperactivity on podocyte actin cytoskeletal dynamics and glomerular barrier function in vivo. Our work will clarify an important downstream mechanism that permits podocyte injury originating from dysregulated TRPC6. Our findings may have broad implications for the understanding of the pathobiology of TRPC6-related human kidney diseases including Focal Segmental Glomerulosclerosis (FSGS) and promote the development of anti-proteinuric drugs interfering with TRPC6 and its cellular effects on podocytes.

Public health relevance
PUBLIC HEALTH RELEVANCE: The broad, long-term goal of this grant proposal is to advance our understanding of podocyte biology and the molecular mechanisms leading to proteinuria and nephrotic syndrome that originate from podocyte injury. If our hypothesis is correct, our work may have broad implications for the understanding of the pathobiology of TRPC6-related human kidney diseases including Focal Segmental Glomerulosclerosis (FSGS) and promote the development of anti-proteinuric drugs interfering with TRPC6 channel function. PUBLIC HEALTH RELEVANCE STATEMENT The broad, long-term goal of this grant proposal is to advance our understanding of podocyte biology and the molecular mechanisms leading to proteinuria and nephrotic syndrome that originate from podocyte injury. If our hypothesis is correct, our work may have broad implications for the understanding of the pathobiology of TRPC6-related human kidney diseases including Focal Segmental Glomerulosclerosis (FSGS) and promote the development of anti-proteinuric drugs interfering with TRPC6 channel function. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS Podocyte foot processes (FP) and the slit diaphragm (SD) are critical components of the permeability barrier in the kidney. Gain-of-function mutations in the TRPC6 gene were identified as a cause for progressive kidney failure and Focal Segmental Glomerulosclerosis (FSGS) in adults1,2 and most recently in children3. TRPC6 is part of the SD relating Ca2+ signals into podocyte FP2. Expression of wildtype TRPC6 protein is induced in a subset of acquired human and rodent proteinuric diseases3. We recently found that the Ca2+-activated calcineurin phosphatase pathway in podocytes is a critical downstream effector of Ca2+ in podocyte FP4. This pathway has been shown to play a key role in the regulation of synaptopodin, the podocyte actin cytoskeleton and glomerular filter function4. We have generated novel data suggesting a unique regulatory loop between TRPC6 and synaptopodin. Synaptopodin interacts with TRPC6 and regulates its membrane localization. In disease, this loop can be dysregulated whereby increased TRPC6 expression and/or activity activates calcineurin which leads to synaptopodin dephosphorylation and subsequent degradation by cathepsin L. In contrast, too little TRPC6 (TRPC6 knockout/knockdown) leads to reduced protective synaptopodin phosphorylation, and contribute this way to synaptopodin degradation. Normal TRPC6 level/activity regulate the physiological stability of synaptopodin and thus glomerular permeability. Key observations: Figure 1. Working model. Functional TRPC6- synaptopodin (synpo) loop. Under normal conditions, synpo is preserved from degradation when phosphorylated by CaMKII/PKA. Synpo interacts with TRPC6 and facilitates its membrane localization. This feedback loop maintains physiological synpo levels allowing for a dynamic regulation of the podocyte actin cytoskeleton Glomerular disease is associated with increased TRPC6 levels/activity and promotes Ca2+- calcineurin axis and synpo degradation. • Mice overexpressing wt-TRPC6 or mutant TRPC6 in podocytes develop proteinuria and FSGS-like lesions. • Overexpression (disease) of TRPC6 in podocytes lead to significant reduction of synaptopodin and F-actin via the calcineurin pathway. • Synaptopodin interacts with TRPC6 and promotes localization of TRPC6 at the plasma membrane. • Synaptopodin enhances TRPC6 channel currents. • Knockdown of TRPC6 leads to decreased activity of protein kinase A (PKA) and loss of synaptopodin. • Activation of PKA by Forskolin induces synaptopodin and rescues F-actin in TRPC6 knockdown podocytes. • Normalization of TRPC6 expression during glomerular disease using in vivo delivery of TRPC6 siRNA to podocytes or the expression of a dominant-negative TRPC6 normalize synaptopodin expression and strongly reduce proteinuria. Hypothesis: (Fig. 1): TRPC6 and synaptopodin are key elements of a functional Ca2 circuit that co-regulate each other. Increased TRPC6 channel activity (mutation or increased expression) disrupts normal podocyte actin cytoskeletal dynamics via the degradation of synaptopodin thereby causing proteinuric kidney disease. To test this hypothesis, we propose the following three Specific Aims: Specific Aim 1 Role of TRPC6 in synaptopodin-mediated podocyte cytoskeletal dynamics 1.1 Study whether preservation of synaptopodin rescues podocytes from the TRPC6 hyperactivity phenotype 1.2 Study whether CaMKII/PKA activity in podocytes is (partially) dependent on TRPC6 Specific Aim 2 Role of synaptopodin in the regulation of TRPC6 channel activity 2.1 Study whether the stimulation of TRPC6 by synaptopodin depends on synaptopodin phosphorylation 2.2 Investigate whether synaptopodin degradation fragments are sufficient to stimulate TRPC6 2.3 Define the biochemical interaction of TRPC6 with synaptopodin 2.4 Investigate the effect of synaptopodin on TRPC6 levels at the plasma membrane Specific Aim 3 Consequences of too little or too much TRPC6 in vivo 3.1 Study the response of TRPC6 -/- mice from LPS- and PS-induced podocyte injury 3.2 Characterize TRPC6-overexpressing mice that express a degradation-resistant form of synaptopodin